Geospatial drivers of cancer care disparities and their susceptibility to health policy changes

Project Summary
Lack of insurance coverage and individual income have been associated with considerable disparities in
cancer care for patients with solid organ malignancies, including later stage disease at time of presentation,
decreased probability of undergoing cancer-directed surgery, and decreased survival. However, much less is
understood about upstream geospatial determinants of health that influence access to and receipt of care for
the 20% of Americans that live in rural communities. Furthermore, the degree to which recent health policy
changes have impacted cancer care delivery for patients living in rural and socioeconomically vulnerable
communities remains unclear. To address these gaps, Dr. Loehrer plans to conduct a population-based
observational and quasi-experimental cohort study to evaluate the influence of rural residence, community-
level socioeconomic deprivation, and their interaction with insurance coverage on presentation with and
management of solid organ malignancies. Additionally, we will evaluate the degree to which Affordable Care
Act associated insurance expansion influenced cancer care delivery across rural and socioeconomically
diverse communities. The study capitalizes on the novel use of select state cancer registries with
geographically linked measures of community-level socioeconomic deprivation. Multilevel quantitative
methods, geovisualization, geocomputational approaches, spatiotemporal analyses, and econometric
modelling will all be used to describe and visualize complex relationships between insurance coverage, rural
residence, local community-level socioeconomic factors in addition to determining the influence of state-level
insurance expansion on disparities in cancer care delivery. The study will provide important information on
upstream geospatial drivers of cancer care disparities while also evaluating the heterogeneous influence of
health policy on rural cancer disparities.
Dr. Loehrer is a surgical oncologist and health services researcher at Dartmouth-Hitchcock Medical Center and
The Dartmouth Institute for Health Policy and Clinical Practice. His clinical practice includes care for patients
with skin, soft-tissue, and liver malignancies while his academic focus is at the intersection health policy, social
determinants of health, and equity of cancer care delivery. His long-term career goal is to become an
innovative and independently funded health policy researcher with a focus on vulnerable populations. The
research plan presented complements both career development and training plans that are focused on
geospatial methodologies and application. The award will lay the methodological and policy foundation for
follow-up studies on state-specific waivers in Medicaid delivery that are too early to be evaluated at present.

Public health relevance
Project Narrative Although 20% of Americans live in rural communities, there are significant gaps in our understanding of rural cancer care disparities, the influence of community-level social determinants of health, and efficacy of policy solutions to improve equity of cancer care delivery. Utilizing multilevel modelling, geocomputational and spatiotemporal approaches, and econometric methodology, this research will determine the extent to which rurality and community-level socioeconomic deprivation influence disparities in cancer care delivery and how they interact with other social determinants of cancer care, including insurance coverage. Further, the project will assess the degree to which health insurance expansion influences care delivery across rural and socioeconomically strained communities.